Risk and strength: determining the impact of area-level racial bias and protective factors on birth outcomes

PROJECT SUMMARY
Our parent grant focused on using deep machine learning models to analyze the text of social media data to
create area-level measures of racial sentiment and to link them with birth outcomes. We focused solely on
race-based biases and did not analyze visual representations of bias. The promising findings from this work
open up questions about the generalizability of this approach for investigating additional health disparities
across other intersecting identities like gender and sexual orientation. We also seek to develop new AI/ML
methods to derive sentiment from image-based content, which is an increasingly common form of
communication on social media. The administrative supplement will allow us to advance this AI/ML area by
making the data AI/ML ready for image analysis, training multimodal models that incorporate both text and
image analysis, and creating valuable resources that will shorten the time and specialized expertise needed to
implement machine learning models to investigate the impact of area-level biases on health inequities. We will
be sharing our AI/ML-ready social media-derived measures by creating a public geoportal for interactive data
visualization and sharing, which will contain repositories of aggregated data that will facilitate the use of this big
data source for future applications in health equity research.

Public health relevance
PROJECT NARRATIVE Social media data represents a rich but relatively untapped resource of public sentiment toward racial/ethnic, gender, and sexual identities for public health researchers. However, its usage has been limited because of the large amounts of unstructured text and image data from social media sources that are not AI/ML-ready and often require expertise in data science or computer science to collect, clean, and process. This project will further advance the study of structural and cultural factors contributing to health inequities by providing a new data repository of social media text and image data that is AI/ML-ready for the investigation of the impact of area-level bias on health.